Local and peripheral mechanisms of T cell-mediated immune regulation after lung transplantation

PROJECT SUMMARY / ABSTRACT
Long-term outcomes after lung transplantation continue to be limited by the development of chronic lung allograft
dysfunction, which may result from breakdown of immunoregulatory circuits. We have shown that deleterious
alloimmune responses are downregulated through immune cell encounters in tertiary lymphoid organs that are
induced in tolerant lung allografts. Our research has shown that Foxp3+ cells that accumulate in these structures
play a central role in maintaining a tolerant state, both locally and peripherally. We have demonstrated that
tertiary lymphoid organs in tolerant lung allografts are dynamic and that continuous recruitment of Foxp3+ cells
is required to maintain tolerance. Furthermore, Foxp3+ cells that enter tolerant lung allografts acquire unique
phenotypic and transcriptional characteristics, including increased expression of amphiregulin and CTLA4. In
this project we will examine the role of amphiregulin in maintaining lung allograft tolerance vs. mediating chronic
lung allograft dysfunction (Aim 1). We will assess mechanisms how Foxp3+ cells maintain local and peripheral
tolerance (Aim 2). We will also evaluate the role of antigen presentation by stromal cells that are prevalent in
tertiary lymphoid organs of tolerant lung allografts (lymphatic endothelial cells, fibroblastic reticular cells) in
maintaining tolerance (Aim 3). In conjunction with Projects 2 and 3, these proposed studies will lay the foundation
for new therapeutic strategies to improve outcomes after lung transplantation.